Extrarenal Functions of Polycystin-1

DESCRIPTION (provided by applicant): Pkd1 encodes PC1, a transmembrane receptor-like protein, and Pkd2 encodes PC2, a calcium channel, which interact to form functional polycystin complexes that are widely expressed in many tissues and cell types. Inactivating mutations of PKD1 or PKD2 genes cause Autosomal Dominant Polycystic Kidney Disease (ADPKD). Studies of ADPKD have elucidated the functions of polycystins and their interdependence on primary cilia in renal epithelial cells; however, they have provided only a limited window into the potential broader functions of polycystins/primary cilia complexes in other tissues, such as bone. We have found that Pkd1 and Pkd2, as well as primary cilia are present in osteoblasts and osteocytes, that primary osteoblasts derived from Pkd1 null mice have impaired osteoblast differentiation capacity and a propensity to differentiate in to adipocytes in vitro, and that conditional deletion of Pkd1 in mature osteoblasts of mice results in osteopenia due to impaired osteoblast-mediated bone formation that is also associated with increased bone marrow adipogenesis in vivo. These findings suggest that polycystins and primary cilia have important biological function in bone. To further examine the skeletal functions of polycystins, we will use osteoblast-lineage specific promoter-Cre mice to selectively delete Pkd1 and Pkd2 from different stages within the osteoblastic lineage, including pre-osteoblasts, mature osteoblasts and osteocytes. To explore potential interdependence of polycystin and primary cilia in bone, we will examine the effect of bone-specific deletion of Kif3a to disrupt primary cilia formation in the osteoblastic lineage. We propose the hypothesis that the loss of polycystins results in the inability of pre-osteoblasts, mature osteoblasts, and osteocytes to maintain their stage of differentiation and survival, resulting in cells reverting to a proliferative, less differentiated state and responding abnormally to the multitude of environmental clues affecting skeletal development and bone formation postnatally. Overall, our studies will define the polycystin/primary cilium complex as a new anabolic pathway in bone as well as possibly provide a new target for developing anabolic agents to treat osteoporotic disorders. In addition, a greater knowledge of specific functions of polycystins in bone will help clarify their overall functions that will translate back to the kidney and other tissues.

Public health relevance
PUBLIC HEALTH RELEVANCE: We have discovered that polycystins and primary cilia play important roles in skeletal development and postnatal bone function through mouse genetic studies that conditionally deleted Pkd1 and Kif3a from the osteoblast lineage in vivo. These findings suggest that the primary cilium/polycystin complex acts as a hub to sense environmental clues and translate them into multiple signaling pathways that sustain osteoblastic development and sustain the differentiated state of mature osteoblast, which lead to a net positive effect on bone mass; and as such, represent a new area of bone biology and an identification of a novel molecular target to design anabolic treatments for osteopenic disorders. In addition, a greater knowledge of polycystins and primary cilia functions in a different cellular context could translate into a broader understanding of their functions in the kidney. Relevance We have discovered that polycystins and primary cilia play important roles in skeletal development and postnatal bone function through mouse genetic studies that conditionally deleted Pkd1 and Kif3a from the osteoblast lineage in vivo. These findings suggest that the primary cilium/polycystin complex acts as a hub to sense environmental clues and translate them into multiple signaling pathways that sustain osteoblastic development and sustain the differentiated state of mature osteoblast, which lead to a net positive effect on bone mass; and as such, represent a new area of bone biology and an identification of a novel molecular target to design anabolic treatments for osteopenic disorders. In addition, a greater knowledge of polycystins and primary cilia functions in a different cellular context could translate into a broader understanding of their functions in the kidney. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Pkd1 is an ancient conserved gene that encodes polycystin-1 (PC1), a transmembrane receptor-like protein, which links environmental clues to intracellular processes regulating cell growth and development. Pkd2 en- codes polycystin-2 (PC2) a transient receptor potential channel which interacts with PC1 to form functional polycystin complexes. Polycystins localize to various cell surface sites where they may be involved in cell-cell and cell-matrix interactions and are also found in primary cilia. The specific "ligand" for Pkd1 is not known, but this protein may function as a chemosensor, mechanosensor via primary cilium, and/or mediator of cell-cell or cell-matrix interactions. The functions of polycystins have largely been derived from the study of Autosomal Dominant Polycystic Kidney Disease (ADPKD), which is caused by inactivating mutations of either PKD1 or PKD2. Pkd1 and Pkd2, however, are widely expressed in many tissues and cell types, but the functions of polycystins are understood less well in other tissues, such as bone. We have strong evidence that polycystin-1 is an important regulator of skeletal development and postnatal osteoblast function. Both polycystins and primary cilia have been identified in the cells within the osteoblastic lineage. In addition, global ablation of Pkd1 causes a severe skeletal dysplasia. We have found evidence that these skeletal abnormalities are directly caused by loss of Pkd1 in osteoblasts, rather than indirect conse- quences of cystic disease of the kidney, since conditional deletions of Pkd1 in osteoblasts and osteocytes cause significant osteopenia in mice (See Preliminary Studies). Finally, a role for primary cilia and a possible con- nection to polycystins in the osteoblastic lineage is supported by the development of osteopenia following the conditional deletion of Kif3a from mature osteoblasts. To further explore the role of primary cilium/polycystin complex in bone development, we propose to confirm and expand our understanding of the functions of PC1, PC2 and primary cilia in bone development and post-natal skeletal homeostasis in vivo. These studies will use the experimental paradigm of conditional dis- ruption of Pkd1 (the gene encoding PC1), Pkd2 (the gene encoding PC2 that binds to PC1 to form the polycystin complex), and Kif3a (a gene required for ciliogenesis) using promoter-driven Cre to target various stages within the osteoblast lineage in vivo. Our Specific Aims are to: 1. Confirm the role of PC1, PC2 and primary cilia in post-natal osteoblast function by creating and charac- terizing mice with Oc-Cre- and Dmp1-Cre mediated conditional deletion of Pkd1, Pkd2 and Kif3a in osteoblasts and osteocytes, respectively. 2. Establish the role of PC1, PC2 and primary cilia in the osteoblast development by creating and charac- terizing mice with Col1(a)3.6-Cre-mediated conditional deletion of Pkd1, Pkd2 and Kif3a throughout the osteoblastic lineage beginning early in bone development.